Computing Core

COMPUTING CORE
SUMMARY
The Computing Core supports the research computing needs of participating faculty members
in the Center for Visual Science. The Computing Core supports the services of three computer
programmers who provide CVS faculty with the expertise to develop customized software
platforms and novel instruments that enable new research directions. Computing core staff bring
years of expertise with 3D graphics programming, real-time control of hardware, image
acquisition and analysis, distributed network analysis, and many forms of sophisticated data
processing. During the coming project period, the Computing core will contribute to a number of
exciting new research directions in CVS, including high-resolution imaging of cellular-level
structure and blood flow in the retina, virtual-reality-based training for rehabilitation of patients
with impairments due to stroke or traumatic brain injury, and the study of corneal biomechanics
underlying the function of new techniques for refractive vision correction.